The Pathogenic Role of IL-33 in the SARS-CoV-2-Infected Lung

ABSTRACT
Severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2), the causative agent of coronavirus disease
2019 (COVID-19), remains a significant threat to global public health. Pulmonary immunopathological damage
plays a role in driving pneumonia, acute respiratory distress syndrome (ARDS), and multiorgan failure in severe
COVID-19. Therefore, dissecting the pulmonary immune response to SARS-CoV-2 infection is critical to under-
stand disease pathogenesis and develop more effective therapeutics. Targeting of type 2 immune pathways is
a potential avenue of therapeutic intervention in severe COVID-19. In particular, research has demonstrated a
link between the type 2 cytokine IL-13 and COVID-19 severity. This proposal builds on the preliminary experi-
ments demonstrating that blockade of the alarmin cytokine IL-33 confers protection in a mouse model of COVID-
19. IL-33 is a potent inducer of type 2 immunity in the lung, as its receptor ST2 is constitutively expressed by
type 2 cells including type 2 innate lymphoid cells (ILC2s). It is hypothesized that IL-33/ST2 signaling induces a
pathogenic inflammatory environment in the acutely infected lung by activating IL-13-secreting ILC2s and that
IL-33-mediated inflammation enhances disruption of the respiratory epithelial barrier. To test this hypothesis, the
impact of IL-33/ST2 signaling axis blockade on the inflammatory environment in the acutely infected lung will be
described through assessment of the immune cell populations and the transcriptional profile of the respiratory
epithelium (Aim 1). Considering that SARS-CoV-2-mediated ARDS is characterized by pulmonary inflammation
and respiratory epithelial barrier disruption, these descriptive studies will elucidate pathways through which IL-
33 may drive pathogenesis. Further, the mechanism through which the IL-33/ST2 signaling axis drives patho-
genesis will be directly tested (Aim 2). Mouse models of ILC2 depletion, selective ST2 knockout in ILC2s, and
adoptive ILC2 transfer will be used to test whether IL-33-activated ILC2s drive pulmonary pathogenesis in the
context of acute SARS-CoV-2 infection. Collectively, the proposed experiments will determine the mechanism
underlying IL-33-mediated pathogenesis. This research is significant because it will further our understanding of
how modulation of type 2 immunity can serve as a novel and promising therapeutic strategy in the treatment of
respiratory viral infection-induced pulmonary pathology.

Public health relevance
PROJECT NARRATIVE Severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2), the causative agent of coronavirus disease 2019 (COVID-19), remains a significant threat to global public health. The alarmin cytokine IL-33 drives patho- genesis in a mouse model of COVID-19 and has been associated with disease severity in human patients. The proposed research will seek to elucidate this therapeutically relevant target by determining the mechanism through which IL-33 impacts pulmonary pathology of SARS-CoV-2 infection.